Understanding the role of RAMS11 in non small cell lung cancer

Our research focuses on understanding how long noncoding RNAs (lncRNAs) promote non-small cell lung
cancer (NSCLC) to address the critical need for improved biomarkers and targeted therapies. Lung cancer is
currently the leading cause of death worldwide, accounting for more than 150,000 deaths a year in just the
United States. Approximately 85% of lung cancer patients have NSCLC and over 50% of these patients
present with metastasis at their initial diagnosis. Historically, NSCLC research has primarily focused on the
deregulation of protein-coding genes to identify oncogenes and tumor suppressors as potential diagnostic and
therapeutic targets, thereby under-representing the emerging roles of long non-coding RNAs (lncRNAs). To
address this critical knowledge gap, we focused on the discovery and functional characterization of novel
lncRNAs that promote tumorigenesis and aggressive phenotypes in NSCLC patients. Through a pan-cancer
computational analysis we discovered that the expression of our recently discovered oncogenic lncRNA, RNA
associated with metastasis 11 (RAMS11), was elevated in NSCLC patients harboring mutations in the NRF2
signaling pathway (NRF2 activating mutations and KEAP1 inactivating mutations). Our preliminary data shows:
(1) RAMS11 promotes aggressive phenotypes, (2) NRF2 transcriptionally activates RAMS11 by binding to its
promoter region, (3) RNA-Seq analysis of models manipulating NRF2 and/or RAMS11 revealed overlapping
downstream regulatory programs, (4) NRF2 and RAMS11 interact, and (5) NRF2 transcriptional regulation of
canonical targets was dependent on RAMS11 expression. Notably, while NRF2 is dependent on RAMS11 to
transcriptionally regulate canonical target genes activated in lung epithelial cells and NSCLC cells, we also
demonstrated that RAMS11 may mediate a cancer specific NRF2 regulatory program. Collectively, this serves
as a strong rationale for our hypothesis that RAMS11 is necessary to confer NRF2-dependent oncogenic
phenotypes in NRF2/KEAP1 mutant NSCLC lung cancer patients. Here we will determine the role of RAMS11
dependent NRF2 transcriptional regulation of cancer-specific, non-canonical target genes and evaluate how
RAMS11 interacts with NRF2. Our proposal will significantly advance the lncRNA tumor biology field by
providing the first evidence of RAMS11-dependent NRF2 regulation to confer oncogenic phenotypes in
vitro and in vivo.

Public health relevance
Lung cancer research has primarily focused on the deregulation of protein-coding genes to identify oncogenes and tumor suppressors as potential diagnostic and therapeutic targets, thereby under-representing the emerging roles of long non-coding RNAs (lncRNAs). Our proposal focuses on how our recently discovered lncRNA, RAMS11, confers NRF2-dependent oncogenic phenotypes in NRF2/KEAP1 mutant NSCLC lung cancer patients. A better understanding of how this lncRNA functions could lead to the development of specific treatments to improve patient outcomes.